CORE--RECRUITMENT AND ASSESSMENT

reviewed on a regular basis for funding from Center financial resources. Finally, clinical fellows in geriatric medicine and psychiatry will continue to be integrated into core CRC activities and individual projects.